Investigation of the dynamics and mechanisms of colitis-induced neuroinflammation

PROJECT ABSTRACT
Inflammatory bowel diseases (IBDs), which entail debilitating gastrointestinal symptoms, affect millions of
people worldwide. Interestingly, IBD patients suffer from anxiety & depression more often than the general
population. Gastrointestinal symptoms of human IBDs are typically chronic and relapsing, but the co-occurring
psychological abnormalities are relatively constant. Some studies have investigated the effect of active
intestinal inflammation on the brain, but little work has been done to characterize changes to the brain during
relapsing intestinal disease remission, when behavioral symptoms remain. Thus, the long-term goal is to
understand colitis-induced neuroinflammatory dynamics and the mechanism through which they are conveyed.
Neuroinflammation can be deleterious to the brain and contributes to the progression of many psychological &
neurological diseases. The Round lab has identified two major neuroinflammatory phenotypes that may be
contributing to the intestinal inflammation-induced psychological manifestations: (1) Calprotectin is elevated in
the brain early and persistently during relapsing intestinal insult, and (2) monocyte and neutrophil infiltrate the
brain ten days after colitis induction. Calprotectin can stimulate inflammation, leukocyte recruitment, and
apoptosis in a variety of tissues and disease contexts; however, it is not well understood how calprotectin
contributes to persistent colitis-induced neuroinflammation or what the functional role of the infiltrating immune
cells is. Aim 1 will determine what cell type in the brain is responsible for the elevated calprotectin and its
necessity for immune cell recruitment. Aim 2 will determine whether these cells are facilitating brain tissue
repair or destruction. Finally, the mechanism of gut-brain communication during colitis still needs elucidation. It
has been demonstrated that colitis can increase bone marrow granulopoiesis; thus, Aim 3 will test if changes in
bone marrow during colitis are persistent and contribute to brain immune cell infiltration. Overall, this proposal
will test the hypothesis that relapsing intestinal insult leads to elevated brain calprotectin levels that recruit
multifunctional immune cells borne of persistently reprogrammed progenitor cells. In conclusion, this work will
significantly enhance our understanding of the gut-brain axis during intestinal disease which can be leveraged
for therapeutic benefit. This proposed research will facilitate the training of the applicant, Michaela Murphy, to
prepare her for her career goal of becoming an independent scientific investigator in the gut-microbiota-brain
axis field. It will develop her skills in 4 areas: (1) Knowledge & Experimental Design, (2) Technical Research
Skills, (3) Science Communication, (4) Teaching & Mentorship, and (4) Leadership & Collaboration. Her
sponsor, Dr. June Round, has the mentoring experience, supportive environment, and scientific expertise to
ensure the successful execution of Michaela’s training plan, and the University of Utah provides ample
resources to facilitate the efficient completion of this project and Michaela’s professional development.

Public health relevance
PROJECT NARRATIVE: The incidence of IBD and its co-occurring mental health disorders are widespread, but little is known about how intestinal disease persistently influences the brain. This proposal will investigate neuroinflammation and bone marrow granulopoiesis during relapsing intestinal insult. As such, this work will contribute to the NIH mission of developing fundamental knowledge that can help reduce the burden of human disease & disability.